Genetic and Functional Traits of Cultivated Nasal Bacteria in Relapsing Granulomatosis with Polyangiitis

PROJECT SUMMARY/ABSTRACT
Granulomatosis with polyangiitis (GPA) is a systemic vasculitis characterized by granulomatous inflammation
and frequent relapses. Rhinosinusitis is a distinguishing feature of GPA and associated with a higher risk of
relapse. While our knowledge of the immunopathogenesis of GPA has advanced, little is known about the
triggers of disease activity. In particular, two questions remain unanswered: 1) what ignites disease activity in
GPA? 2) why, despite similarities in clinical presentation and immunosuppressive therapy, are some patients
more likely to relapse than others? Mechanistic and epidemiologic studies suggest microbes, in particular
nasal microbiota, may be an important environmental activator of GPA. To deepen our understanding of the
potential effects of the nasal microbiome on disease activity in GPA, our group used high-throughput
sequencing methods to comprehensively investigate the thousands of resident microbiota in the nasal cavity of
patients with GPA. Our preliminary findings using 16S gene sequencing showed dynamic changes in the nasal
microbiome prior to the onset of relapse in GPA and, conversely, temporal stability in those with quiescent
disease. Sequencing the 16S gene was an appropriate initial approach to characterize the microbiome but is
limited in species/strain resolution (identifies genus level at best) and ascertaining functional information. In
order to investigate the hypothesis that species- and strain-specific interactions between nasal bacteria
activate the mucosal immune response in the nasal cavity of patients with GPA, we first need to: 1) increase
taxonomic resolution to identify species/strains of bacteria associated with GPA relapse, 2) demonstrate
feasibility of culturing bacteria of interest for use in future mechanistic studies, and 3) evaluate whether
microbial genetic pathways (e.g., metabolites or virulence-related genes) are associated with relapse in GPA.
The objective of the proposed study is to identify, culture, and functionally characterize the bacterial species
and strains that are associated with disease activity in patients with GPA. Beyond taxonomic identification
(what microbes are present), understanding the functional composition (what can the microbes do) may
discover the mechanisms in which microbes incite or perpetuate autoimmunity. This work will directly lead to
deeper investigations into the mechanisms used by nasal bacteria to activate host immunity. Understanding
the key genetic and functional traits that affect host physiology and mediate cross-species relationships may
lead to the development of novel therapies targeting microbes or their products as well as biomarkers of early
disease detection in GPA.

Public health relevance
PROJECT NARRATIVE Granulomatosis with polyangiitis (GPA) is a systemic vasculitis with a predilection for the upper respiratory tract and is plagued by frequent relapses. The proposed study will provide new insight into the role of nasal bacteria in mediating disease activity in GPA and advance our knowledge of host-microbe interactions in autoimmunity. Identifying the triggers that elicit an autoimmune response in GPA may help identify those patients at highest risk for relapse and lead to novel, more personalized treatment strategies.